The role of IL6-induced LAG3 as a resistance mechanism to PD1 blockade in NSCLC patients

PROJECT SUMMARY/ABSTRACT:
Despite the landmark approval of anti-PD1 therapy for non-small cell lung cancer (NSCLC), the majority of
patients still progress. Compensatory activation of lymphocyte activation gene 3 (LAG3), to suppress T cell
activation is an established mechanism of resistance to anti-PD-1 therapy in cancer. Our recent work suggests
that IL-6 is an upstream inducer of LAG3 in patients with NSCLC. We have demonstrated an association
between IL-6 and STAT3 activation and decreased response in patients with NSCLC receiving anti-PD-1
therapy. However, we do not know (1) the mechanism of IL-6-induced LAG3 expression which leads to anti-
PD-1 resistance, or (2) if IL-6 blockade prevents T cell dysfunction in vivo. This proposal hypothesizes that (1)
increased plasma IL-6 induces LAG3 expression via STAT3 activation in peripheral CD8+ T cells leading to T
cell dysfunction and decreased response to anti-PD-1 therapy in patients; and (2) LAG3-mediated T cell
dysfunction can be rescued with IL-6 blockade in vivo. This proposal will significantly impact future studies
regarding immunotherapy resistance in cancer. Specifically, this project will inform our understanding of a
novel IL-6-induced LAG3 mediated mechanism of anti-PD-1 resistance and will serve as the pre-clinical
rationale for investigating the combination of IL6/STAT3 inhibition and PD-1 blockade in an early phase clinical
trial for patients with advanced NSCLC. This proposal will provide Dr. Somasundaram with the opportunity to
continue work with (i) animal models (design and oversee murine models), (ii) quantify changes in tumor size,
volume and number in mice, and (iii) evaluate the immune landscape in murine T cells by
immunohistochemistry (IHC) and flow cytometry, and RNA sequencing (RNAseq). He will continue his current
work with patient samples also. These skills will be reinforced by a team of mentors, advisors, collaborators,
and core resources available at the University of North Carolina and the University of Pittsburgh. The primary
mentor, Dr. Jonathan Serody, is an internationally recognized, NIH R01-funded scientist with 28 years of
experience in tumor immunology, and co-mentor, Dr. Dario Vignali, is an NIH R01-funded tumor immunologist
with decades of experience in murine research. Also, an advisory committee of accomplished investigators
with expertise in tumor immunology, IL-6, LAG3, PD-1, and NSCLC will monitor Dr. Somasundaram’s progress
with quarterly meetings ensuring the completion of Dr. Somasundaram’s short-term goal of scientific
independence and long-term goal of becoming a tenure-track physician-scientist with expertise in systemic
inflammation, tumor immunology, checkpoint blockade resistance, and NSCLC. The results from this proposal
will form the basis for an R01 studying the translational role of IL6 induced anti-PD-1 resistance in NSCLC.

Public health relevance
PROJECT NARRATIVE: Non-small cell lung cancer (NSCLC) leads to more cancer death annually than any other cancer, and despite the landmark approval of anti-PD-1 therapy for NSCLC, the majority of patients still have progressive disease. The IL-6/STAT3 pathway has been identified in association with decreased response to anti-PD-1 therapy in NSCLC patients, but the mechanism by which IL-6 leads to anti-PD-1 resistance is poorly understood. This proposed study will advance our basic understanding of IL-6-mediated anti-PD-1 resistance, and inform future combination therapy development in NSCLC for patients that have not responded to anti-PD-1 therapy.